ASBESTOS EFFECTS ON HUMAN ALVEOLAR MACROPHAGE FUNCTIONS

The purpose of this study was to determine the in vitro effects of amosite asbestos on normal human pulmonary alveolar macrophage functions and normal human peripheral blood B-cell and T-cell responses.